Clonal Evolution in Multiple Myeloma

ABSTRACT A major goal of this application is to conduct the translational work required to foreshadow the introduction of a next generation sequencing clinical diagnostic in Multiple Myeloma (MM). Underpinning this goal, we designed and piloted an innovative, MM specific, 77-gene panel (M3P). The panel requires minimal DNA quantities, generating sequence at significant depth while simultaneously tracking copy number and presence of common amplifications and deletions. Using this novel resource and capitalizing on the extensive clinically annotated, tissue banks and patient populations at Mayo, we will, for the first time be able to address the prevalence, prognostic implications, and effect on therapeutic responses of each of the common mutations identified in MM cells in large series of patients at relatively low cost. In Aim 1 we will interrogate each of the 77 most commonly mutated, or drug resistance related genes, individually or when assembled by pathways or non-supervised clusters in tumor DNA from 726 newly diagnosed patients. This work will define the spectrum and frequency of mutations in this population; correlate the presence of individual mutations to baseline clinical and laboratory characteristics, response to therapy, and their contribution to relapse and survival. In Aim 2 we will track clonal evolution of disease before, during and after therapy including in states of minimal surviving disease and in earlier “precursor” cell compartments. Specifically, we will conduct a prospective, phase 2 clinical trial across all Mayo sites enrolling 124 relapsing patients assigned to treatment with pomalidomide and dexamethasone alone or the same drugs in combination with carfilzomib. M3P sequencing will be used to characterize the mutational profile and clonal diversity of the surviving tumor clone in different marrow compartments and in peripheral blood; pre therapy, at end of cycle 2, and at 6 months. Finally, in Aim 3 we will generate unbiased sequence data on the mutational profile in general, and the frequency of CRBN/IZKF1/IKZF3/IRF4, IRE1/XBP1s or NR3C1 mutations in particular, contributing to drug resistance in highly drug resistant patients. To cover known, but also seek new mutations, we will use whole exome and RNA sequencing to examine for the first time the molecular profile of truly drug refractory MM in 60 patients with a marrow sample taken within 6 months of death from MM or at time of enrollment on any Phase I trial (including trials in this SPORE application).

Public health relevance
NARRATIVE: A major goal of this application is to conduct the translational work required to foreshadow the introduction of a next generation sequencing clinical diagnostic in Multiple Myeloma (MM). MM remains an incurable disease and development of precision guided therapies based on genomic vulnerabilities have been slow to emerge. Indeed, the landscape of MM genomic mutations at diagnosis is essentially defined however, translating this raw genomic information to clinical knowledge and action is a critical, and important goal, which this application seeks to address in three steps. First: The significance of most newly reported, recurrent mutations (eg. FAM46C, DIS3) at diagnosis is simply not known, therefore, our first aim is to understand their significance at diagnosis with respect to disease biology, prognosis and therapeutic outcomes. Second: Since some small fraction of MM cells are clearly able to withstand even the most aggressive induction chemotherapy it is critical to better understand how the genomic profile of surviving cells and changes in clonal diversity contribute to incomplete response and subsequent relapse. Finally: Most genomes sequenced have been from patients at early stages of disease and it is probable that the genomic landscape in late stage disease and especially during states of drug resistance is unique and ultimately what is lethal to the patient, but genomic data from this patient population is still not available. In summary, deployment of a rapid, inexpensive, reliable and clinically actionable MM specific mutation sequencing panel will provide a pragmatic clinical advance for prognostication, tracking clonal evolution, and monitoring drug resistance emergence.